4th International Conference on Primate Genomics

DESCRIPTION (provided by applicant): This conference grant application requests funds to partially support the "4th International Conference on Primate Genomics." The conference will be hosted by the Washington National Primate Research Center and held April 13-16, 2010 at the Seattle Art Museum in downtown Seattle, Washington. The museum has state-of- the-art conference facilities, including a 293-seat auditorium and private meeting rooms for poster and vendor exhibits. This application seeks funding to cover the costs associated with the rental of this facility. Additional funding for running the conference will come from registration fees paid by conference participants and we are actively seeking sponsorship from foundations and commercial institutions (including pharmaceutical and biotechnology companies). The principal objective of this conference is to serve as a scientific forum at which investigators in the fields of nonhuman primate research, genomics, proteomics, and bioinformatics can discuss new research findings and technological innovations related to the use of genome-based science in nonhuman primate research. The conference will include a focus on genomic and proteomic resource development, advances in computational biology and bioinformatics, and new developments in comparative genomics and evolutionary biology. The 2010 conference will also highlight research activities in which genomics and nonhuman primate models are being used to better understand human disease. The scientific program will be organized by a Scientific Program Committee of local and nonlocal members, all leaders in their fields of expertise. Committee members will select invited speakers and session chairs and will review abstracts submitted by conference registrants for oral and poster presentations. Recent advances in the field, including the sequencing of the rhesus macaque genome, the development of macaque-specific DNA microarrays, and new opportunities for nonhuman primate proteomics make this conference particularly timely and significant. PUBLIC HEALTH RELEVANCE (provided by the applicant): The "4th International Conference on Primate Genomics" serves as a forum at which scientists can discuss new research findings related to the use of new technologies, genome sequence information, and nonhuman primate models of human health and disease. The conference highlights research activities aimed at understanding, preventing, and treating conditions such as viral hepatitis, AIDS, memory loss, drug addiction, and age-related disease.

Public health relevance
NARRATIVE The "4th International Conference on Primate Genomics" serves as a forum at which scientists can discuss new research findings related to the use of new technologies, genome sequence information, and nonhuman primate models of human health and disease. The conference highlights research activities aimed at understanding, preventing, and treating conditions such as viral hepatitis, AIDS, memory loss, drug addiction, and age-related disease.